SITE-SPECIFIC GLYCOSYLATION OF ALPHA-DYSTROGLYCAN FROM RAT BRAIN

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The goal of this collaborative project is to develop methodology to analyze the N- and O-linked glycans expressed on alpha-dystroglycan, with emphasis on determining the O-Man and O-GalNAc sites of glycosylation.